Interdisciplinary approaches for understanding how arsenic and micronutrients affect the epigenome to influence spina bifida risk

PROJECT SUMMARY/ABSTRACT
Neural tube defects, including spina bifida and anencephaly, are common and severe birth defects that occur
when the neural plate, the embryonic precursor to the brain and spinal cord, fails to close during early
gestation. Folic acid fortification and supplementation have helped to reduce the global burden of neural tube
defects; however, less than 50% of neural tube defects are estimated to be attributed to known risk factors.
Arsenic contamination of drinking water continues to be a major public health threat worldwide and has been
shown to induce neural tube defects in animal models. An emerging hypothesis is that arsenic acts via the
epigenome, the multitude of compounds that affect the expression of genes without changing the underlying
DNA sequence. In this ViCTER application, we have established a team of experts in child neurology,
neurosurgery, epigenetics, developmental and molecular epidemiology, functional genomics and biostatistics
to test the hypothesis that DNA methylation mediates the neurotoxicity of arsenic on the developing nervous
system. Better understanding of the interplay of epigenetics, nutrition, and environmental arsenic exposure will
inform strategies to prevent and treat neural tube defects.
In this proposal, we establish a new basic science-clinical science consortium to assess whether arsenic
induces recognizable DNA methylation changes at loci critical for normal neural tube closure. We will utilize in
vitro methods and biological samples collected from an epidemiological study in Bangladesh to measure DNA
methylation patterns using cutting-edge methodologies, including whole genome bisulfite sequencing and the
Illumina EPIC/850K BeadChip technology. Additionally, we will investigate DNA methylation changes in genes
associated with arsenic exposure and folate status following a short course of high-dose folic acid
supplementation in women who previously conceived a child with a neural tube defect.
This interdisciplinary and collaborative study, which includes research activities spanning basic to applied
research, will seek to identify genes involved in neural tube closure that are differentially methylated in relation
to arsenic exposure and folate status. This consortium effort will accelerate the translation of findings into folic
acid-based preventive strategies to reduce the global burden of neural tube defects, particularly in areas with
high arsenic exposure.

Public health relevance
PROJECT NARRATIVE We establish a new basic science-clinical science consortium to assess how arsenic affects the maternal epigenome to increase risk of neural tube defects. We use biological samples collected from an epidemiological study in Bangladesh as well as in vitro methods using cutting-edge technologies, including whole genome bisulfite sequencing DNA methylation arrays. Additionally, we will investigate DNA methylation changes following a short course of high-dose folic acid supplementation among women who had a pregnancy affected by spina bifida.